Systems Genetics of Bone Regeneration

Project Summary:
There are over 1 million cases of failed bone repair in the U.S. annually, resulting in substantial patient
morbidity and societal costs. The genetic factors affecting bone repair are poorly understood because the field
has been limited by having to rely on interrogating genes with known relevance for osteoporosis or other
biological processes such as inflammation. These studies have identified only a handful of genes. In contrast,
systems genetics studies of many phenotypes including skeletal traits such as bone mineral density have
already identified multiple novel genetic variants that can be targeted for therapeutic intervention.
Unfortunately, the study of bone repair in patients is not readily amenable to this approach because of the
difficulty in enrolling patients in studies after the occurrence of the index event, great variability in injury types
and lack of simple readouts to assess repair. These barriers can be overcome by using a model organism with
a well-defined injury mechanism and simple readout to characterize the repair phenotype. Thus, we will use
systems genetics to discover novel genes influencing intramembranous bone regeneration induced by marrow
ablation in a mouse model. Intramembranous bone repair is integral to fracture healing, distraction
osteogenesis, fixation of orthopedic and dental implants to the skeleton and repair of large defects caused by
trauma or necessitated by resection of bone tumors. In Aim 1, we will perform the first genome-wide
association study (GWAS) for bone repair by measuring the intramembranous bone regenerative response
after marrow ablation in Diversity Outbred (N=1000) mice. We will identify genes responsible for bone
regeneration quantitative trait loci (QTL) and expression QTL using multiple fine-mapping approaches and
transcriptomic data generated from single cell RNA-seq. In Aim 2, we will use Bayesian networks and identify
genes highly connected to known regulators of bone traits using Key Driver Analysis to identify candidate
causal genes for the bone regenerative response. In Aim 3, we will validate the role of Periostin, a recently
identified candidate gene, and at least one additional candidate identified in the first two aims. We will begin by
testing the role of Periostin, a gene implicated in intramembranous bone regeneration in preliminary
transcriptomic, lineage tracing and key driver analyses. The project will significantly increase our
understanding of the genetics of bone repair. Genes that we identify will serve as potential therapeutic targets
capable of improving multiple orthopedic and dental procedures which rely on bone repair.

Public health relevance
Relevance to Public Health: Impaired bone repair is a major public health burden. There are over 12 million fractures per year in the U.S., with up to 10% having impaired healing, resulting in substantial patient morbidity and societal costs. This research will identify genes that regulate intramembranous bone regeneration. The results of this project have the potential to lead to a novel treatment for this common disorder.